Development and application of pediatric-specific blood transcriptional modules across diverse geographical settings through public data mining

Project Summary/Abstract
Blood transcriptional modules (BTMs), consisting of functionally related gene sets developed through
dimensional reduction computational methods, have emerged as a significant tool for the biological interpretation
of bulk transcriptomic data. However, current BTMs, primarily derived from North American and European adult
data, fail to capture the immunological characteristics of pediatric populations across diverse geographical
settings. To address this significant gap, we aim to develop pediatric-specific BTMs (pBTMs) that capture the
broad range of heterogeneous physiological states during childhood and include underrepresented pediatric
geographical cohorts through public data mining. For this purpose, we will construct modules utilizing
transcriptome data from children aged birth to 12 years. We have gathered 13,388 samples from 76 studies
across various physiological conditions, enabling the construction of robust and widely applicable pediatric-
specific modules. This work will be the first to establish pediatric-specific BTMs, serving as a valuable resource
for pediatric immunology research and empowering the development of vaccines and therapies to reduce the
burden of infections and other immune-mediated diseases in childhood. This project also aims to address several
limitations of previous frameworks by incorporating an improved a priori knowledge base using pediatric single-
cell datasets and an assessment framework for the biological relevance of the pBTMs using genome-wide
association studies (GWAS). Our state-of-the-art and novel computational framework will be delivered as a
portable, version-controlled, publicly available pipeline that can be replicated in other disease and tissue type
settings. To demonstrate the utility of pBTMs and as a proof of concept, we will utilize these modules to define
immunological differences across geographically disparate pediatric populations, informing research into
variability in childhood immune responses.

Public health relevance
Project Narrative Blood transcriptional modules (BTMs), consisting of functionally related gene sets developed through computational analysis of large amounts of public data, have emerged as a significant tool for the biological interpretation of gene expression data. However, current BTMs, primarily derived from North American and European adult data, fail to capture the immunological characteristics of pediatric populations across diverse geographical settings. To address this significant gap, we aim to develop pediatric-specific BTMs (pBTMs) that capture the broad range of heterogeneous physiological states during childhood and include underrepresented pediatric geographical cohorts through public data mining.